ANTIBODIES TO HIV-1 BY REPERTOIRE CLONING

The proposed research aims to characterize human antibody responses to the HIV-1 virus at the molecular level, and to generate human monoclonal antibodies for clinical evaluation in combatting HIV infection. The latter includes passive immunization as a potential treatment for AIDS and prophylaxis in pregnant women to prevent transmission of the virus to offspring. Panels of antibodies against HIV-1 envelope proteins will be generated by establishing Fab libraries from appropriate donors on the surface of M13 phage and selection of specific Fabs by antigen panning. Fabs will be characterized in terms of in vitro neutralizing ability, antigen affinity, epitope recognized and nucleic acid sequence. Fabs will be linked to Fc genetically for the production of glycosylated whole IgG antibodies in eukaryotic cells. A cocktail of antibodies for therapeutic application will be assembled based on exceptional neutralizing ability, reactivity with multiple viral strains, recognition of different epitopes on the viral envelope and possible synergistic effects. The research will provide opportunities to explore the mechanism(s) responsible for virus neutralization and some of the rules governing antibody recognition of viral antigens.